Cellular tools for studying PKD1 regulation in autosomal dominant polycystic kidney disease

Project Summary
Autosomal Dominant Polycystic Kidney Disease (ADPKD) is incurable, and cellular systems for modeling
the genetics of cystogenesis are needed to understand the underlying pathways and to design
preventatives. Mice do not faithfully recapitulate natural ADPKD, presenting a major limitation to
cystogenesis research. In humans, cysts are formed when the PKD1 gene product, polycystin-1, is
disrupted. Most cysts originate from a somatic “second hit” inactivation of one PKD1 allele, which joins the
inherited pathogenic allele to result in biallelic inactivation. It happens hundreds of times in human ADPKD,
but in mice Pkd1 heterozygotes do not form cysts and the gene escapes mutation. We discovered why, and
will use that information here to create novel cellular tools for ADPKD research. We find that a defining
characteristic of human PKD1 is an unusual capacity to form guanine-quadruplex (G4) DNA structures. G4
DNA is found throughout the genome where it helps regulate gene expression, but it is unusually abundant
in human PKD1. G4 DNA is highly stable in the cell, concentrated in the 5’ region of genes, and is normally
resolved by G4-specific helicases to prevent polymerase stalling and DNA breaks. G4-stabilizing ligands,
reporter assays, and direct visualization in living cells has validated the contributions of G4 DNA to cell
physiology as well as documented the propensity of the structure to increase locus-specific mutagenesis.
Human PKD1 harbors ~10-times more G4 DNA than mouse Pkd1, and we observed G4 formation in human
PKD1 by chromatin immunoprecipitation. Incubation of human cells with a G4-stabilizing ligand resulted in
DNA breaks in PKD1, and lowered its expression. G4 DNA does not measurably form in mouse Pkd1 or
cause DNA breaks in the gene. Since mutagenic inactivation of human PKD1 causes cysts and G4 DNA
provokes breaks in the gene, G4 DNA regulates cystogenesis. Based on that premise, we will develop
pluripotent stem cells altered for PKD1 G4 content, thereby creating a unique tool for cystogenesis
research. In Aim 1 we will transfer two blocks of human PKD1 G4 repeats to mouse Pkd1 in induced
pluripotent stem cells, thereby humanizing the murine ortholog in a cellular system capable of renal cell
development. In Aim 2, we will delete two G4-rich regions (introns 21 and 22) from human PKD1 in
pluripotent stem cells and in HEK293T, providing two novel cell-based reagents for studying the impact of
G4 DNA on polycystin-1 activity in a genetic background amenable to cystogenesis studies. Following their
validation as G4-modified PKD1 cell models, reagents will be made freely available for studies on ADPKD
mechanisms and potential therapeutic interventions.

Public health relevance
Project Narrative Relevance to public health: Autosomal Dominant Polycystic Kidney Disease is caused by loss of the PKD1 gene. This project will create innovative cellular tools for studying PKD1 gene regulation, which will enable advancement of research on cyst forming mechanisms.